Uncovering cerebellar mechanisms of tremor using the efficacy of propranolol to test circuit function

PROJECT SUMMARY/ABSTRACT
Tremor is the most common neurological movement disorder in the world, affecting over 10 million people in the
U.S. alone. Characterized by involuntary, uncontrollable oscillating movements of body parts, tremor is
debilitating to patients and can emerge at any age, in both genders, from genetic or idiopathic origins. Tremor
pathology is thought to involve motor brain centers such as the cerebellum, but the identities of specific cellular
activity patterns and molecular mechanisms underlying tremor remain a mystery. To study these unknowns, I
developed a method of studying tremor using the prescription drug propranolol as a mechanistic tool to uncover
cerebellar pathways and circuit activity patterns that drive tremor, with hopes of revealing potential therapeutic
targets. Propranolol is a β-adrenergic receptor blocker (or beta-blocker) that has been continuously prescribed
to patients as a first-line treatment for tremor since 1965. Though its neural mechanisms for tremor reduction are
not yet understood, propranolol’s high rate of efficacy in tremor patients makes it an ideal and unique tool for the
study of tremor pathology. Motivated by the increasingly extensive literature implicating that cerebellar circuit
activity abnormalities may contribute to tremor, I administered propranolol to mice that exhibit a robust genetic
form of tremor, and found that not only was propranolol highly effective in eliminating the tremor phenotype, but
that cerebellar activity was significantly altered during propranolol’s active tremor reduction. In mice with genetic
tremor, Purkinje cells are known to fire more irregularly and at a much higher firing rate. Using in vivo electro-
physiology, I found that propranolol dramatically reduces Purkinje cell firing rate in mice with genetic tremor.
Moreover, the duration of this reduced firing rate correlated with the duration of decreased tremor severity; once
enough time had passed that propranolol was eliminated from the system, Purkinje rates returned to tremorgenic
levels, and the tremor phenotype returned as well. My data raise the intriguing hypothesis that abnormal firing
patterns of key cells in the cerebellar circuit, such as Purkinje cells whose activity patterns are readily altered by
propranolol, are at the heart of tremor pathology in the brain. To test this hypothesis, I generated two aims to
further uncover the cerebellar functions underlying tremor, using propranolol as a mechanistic tool to test the
molecular genetic properties of the cerebellum in tremor (Aim 1), and to dissect the role of Purkinje cell activity
in generating and reducing tremor (Aim 2). For both aims, I will use genetic crosses to create mice with targeted
manipulations of genes in the cerebellar circuit and in vivo electrophysiology recordings of cerebellar neurons in
behaving animals. The completion of these aims will call for a reevaluation of the unsolved and debated theories
that attempt to explain how tremor begins in the central nervous system, as well as give key insights into how
the most-prescribed tremor drug truly works in patients. The availability of knowledge about the neural circuitry
underlying tremor pathology will provide opportunities for great advancements in both drug-based and alternative
treatments for tremor, such as brain stimulation-based treatments, and ultimately lead us closer to a future cure.

Public health relevance
PROJECT NARRATIVE Tremor is the most common motor disease; it causes rhythmic shaking that impairs walking, speaking, and eating. The tremors are thought to arise from abnormal brain signals, but the cells and circuits that produce these signals remain unknown. I will determine the neural substrates of tremor by studying how propranolol, an efficacious drug for some patients, improves function, with the goal of expanding the benefits to more patients.